EFFECT OF BROMOCRYPTINE ON SERUM CHOLESTEROL

This study was designed to determine the effect of bromocriptine on the levels of serum cholesterol and its major fractions in human subjects with hypercholesterolemia.